MULTIPLE DOSES OF SUBCUTANEOUS RHUIL-10 IN PATIENTS WITH ACTIVE CROHN'S DISEASE

The purpose of the study is to study the safety and tolerance of retreatment with multiple doses of subcutaneous SCH 52000 in patients with chronic active Crohn's disease.